Prevention of post-therapy breast cancer metastasis

Despite advances in standard therapies,30-40% of patients with early-stage breast cancer will develop post-
therapy metastases. Breast cancer stem cells (BCSC) give rise to metastases and are resistant to standard
chemotherapy and radiation therapy. Moreover, radiation (IR) or chemotherapy (chemo) can reprogram
nonstem breast cancer cells into BCSC, namely iBCSC. Thus, effective cancer treatment must eliminate
therapy-resistant BCSC and block formation of therapy-induced BCSC. Both BCSC/iBCSC express elevated
levels of aldehyde dehydrogenase (ALDH). Disulfiram (DSF) is an FDA-approved inhibitor of ALDH for
treatment of alcoholism. Its toxicity to breast cancer cells is enhanced by the binding of the essential trace
element copper (Cu) to form DSF/Cu complexes. DSF/Cu is an effective
proteasome inhibitor
resulting in
inhibition of the key transcriptional factor NF-κB, which is linked to cancer and radio-, chemo-resistance and
Consistent with the most recent epidemiological report indicating that DSF significantly reduced
patient risk of death from cancer, we found that DSF and IR effectively targets BSCS/iBCSC and significantly
prevented lung metastasis in the aggressive mouse mammary tumor 4T1 model, while IR alone was
ineffective. We also found that DSF/Cu can block in vitro and in vivo IR- or chemo-induced BCSC via down-
regulation of the NF-κB-stemness gene pathway and target BCSC by reduction of pro-survival ALDH activity
and induction of endoplasmic reticulum (ER) stress- immunological cell death (ICD). Moreover, DSF and IR
induced a robust immune response against primary tumor and lung metastasis in 4T1 mouse models.
ICD
cell stemness.
These
findings provide the rationale for our hypothesis that DSF/Cu, which induces of therapy-resistant BCSC and
blocks formation of IR- or chemo- induced BCSC, is effective in preventing breast cancer metastasis when
combined with the most frequently used standard treatment, i.e., surgery, IR and chemo.
Since Cu is tumor
promoting and found at elevated levels in tumors and sera of breast cancer patents, tailored use of exogenous
Cu with DSF in vivo will be based on tumor Cu level in all Aims.
In Aim1, we will assess the therapeutic
efficacy of IR and/or chemo combined with DSF/Cu on preventing metastasis of patient breast cancer-derived
xenograft (PDX) and MMTV-PyMT transgenic mammary tumors in an adjuvant setting. In Aim2, we will assess
the therapeutic efficacy of chemo combined with DSF/Cu on preventing metastasis of PDX and MMTV-PyMT
tumors in a neoadjuvant setting. In Aim3, we will
analyze the mechanisms by which DSF/Cu systemically
targets BCSC via induction of ICD and modulation of IR-induced immune response
. At the conclusion of this
study, we will have: i) evaluated DSF/Cu as a novel agent targeting BCSC/ iBCSC in the context of surgery,
chemo-and/or IR treatment; ii)
elucidated mechanisms by which DSF/Cu and IR induce a robust immune
response against breast cancer metastasis; and iii) formed the preclinical foundation for designing a clinical
research program to test this novel therapy to prevent post-therapy breast cancer metastasis.

Public health relevance
Despite the advances made in standard therapies, 30-40% patients with early-stage breast cancer will develop post-therapy metastatic disease, which is responsible for 40,000 deaths annually in the U.S. This grant proposal aims at eradicating the source of metastasis, namely breast cancer stem cells through repurposing a FDA approved drug Disulfiram (known for chronic alcoholism treatment) in combination with standard chemo- and radiation- therapy to prevent post-therapy breast cancer metastasis.